Administrative Core

Administration – Abstract
The Administrative Core represents the management entity designed to provide planning, implementation,
oversight, evaluation and other required administrative functions of our COBRE at the Medical University of
South Carolina (MUSC). It ensures all aspects of the program are carried out as proposed and serves as the
center of communication among faculty, Cores and all internal and external committee members. The
Administrative Core is responsible for and coordinates the following functions: (1) organization, coordination,
and reporting of Center operations, fiscal commitments, recruitment activities and regular committee
assessments; (2) administration and management of enrichment activities and our established Pilot Projects
Program; (3) cost-recovery/membership activities; (4) center evaluation processes and compliance with
institutional, state and federal research policies and regulations. The Administrative Core will support the
capacity of the COBRE to increase its investigators’ competitiveness for NIH funding, integrate its research
infrastructure with relevant research centers and programs at MUSC, encourage entrepreneurial endeavors and
enhance multidisciplinary training of MUSC researchers through development of programmatic research grants
in redox/signaling biology. This component is also instrumental in the preparation of annual progress reports,
maintains the Redox COBRE web site and orchestrates dissemination and access of scientific data and other
information to COBRE participants, center members and to collaborating IDeA programs both within the State
and nationally.